The Role of DHCR7 in Endotoxemia

PROJECT SUMMARY/ABSTRACT
Sepsis is a common and deadly disease and treatment options are limited to antibiotics and supportive care.
Endotoxemia is a key feature of sepsis pathogenesis and can also contribute to numerous other inflammatory
disorders. Growing antibiotic resistance and an aging population have contributed to an urgent unmet need for
new therapeutics for these conditions.
In Dr. Jacob’s published work, she used the endotoxin lipopolysaccharide (LPS) to recapitulate key features
of sepsis pathogenesis. RNA sequencing (RNA-seq) identified cholesterol metabolism as one of the most
significantly altered pathways in LPS treated zebrafish and in sepsis patients with poor outcomes. Specifically,
the mRNA for 7-dehydrocholesterol reductase (DHCR7), which catalyzes the conversion of 7-dehydrocholesterol
(7-DHC) to cholesterol, was significantly upregulated in LPS treated zebrafish and was one of only two lipid-
related gene associated with mortality in sepsis patients. Dr. Jacob made the novel finding that fish treated with
a DHCR7-specific inhibitor were completely protected from endotoxemic death.
Dr. Jacob’s K08 proposal aimed to elucidate the role of DHCR7 in endotoxemia in both zebrafish and
mammalian systems and identify clinically utilized DHCR7 inhibitors that mediate LPS toxicity, with implications
for the development of sepsis therapeutics. Prior to her leave, Dr. Jacob had generated a stable zebrafish
DHCR7 mutant line and had completed proposed experiments in a murine model. This supplement will allow Dr.
Jacob to hire additional personnel to complete the remainder of her mechanistic studies on DHCR7 both in vitro
and in vivo and make up for time away from the laboratory. Thus, Dr. Jacob will emerge from this supplement
period with the ability to expand the translational reach of her findings and successfully compete for independent
funding.

Public health relevance
PROJECT NARRATIVE Sepsis, or dysregulated host response to infection, is one of the most common causes of hospitalization in the U.S. with a high mortality rate. DHCR7, an enzyme involved in cholesterol synthesis, was associated with mortality in human sepsis, and fish treated with a DHCR7 inhibitor were protected from toxicity in a zebrafish model that recapitulates features of human sepsis. This administrative supplement will support the hiring of personnel to compensate for the PI’s time away from the laboratory and will thus allow for completion of experiments that show how DHCR7 inhibition exerts a protective effect, with implications for the development of human sepsis therapeutics.